Molecular and Cellular Mechanisms of Bacterial Cell Wall Constriction and Chromosome Organization

Project Summary
In this funding period, we will investigate the molecular and cellular mechanisms
underlying the spatiotemporal organization and regulation of two essential bacterial cellular
processes, cell wall constriction and chromosome organization, using E. coli as a model
organism. Cell wall constriction is the concurrent new septal cell wall synthesis and old septal cell
wall degradation, which leads to the formation of two new cell poles and the separation of two
daughter cells. Chromosome organization is the three-dimensional arrangement of the
chromosomal DNA, which impacts all aspects of genomic processes, including replication, repair,
and transcription. Past studies have identified many key molecular players involved in these two
processes. However, we still lack fundamental knowledge about how the two processes are
spatiotemporally organized and regulated in living cells. We will address this knowledge gap by
probing the molecular compositions, dynamics, functions, and regulations of key players of the
two processes. We are uniquely positioned for these tasks because of our extensive expertise in
single-molecule imaging and bacterial cell biology, which enables us to directly link a single
protein molecule’s moving dynamics and localizations in live cells with its function and activity.
For the cell wall constriction project, we will identify the molecular composition of the core
septal cell wall synthase complex, molecular mechanisms leading to the highly processive septal
cell wall synthesis of two complementary synthase systems, and the septal localization and
dynamics of cell wall hydrolases. Our overall goal is to elucidate the spatiotemporal coordination
between septal cell wall synthesis and hydrolysis, which must be balanced to ensure robust cell
wall constriction without lesions during cell division.
For the chromosome organization project, we will investigate the roles of a highly
conserved nucleoid-associated protein HU, small noncoding RNAs, and DNA supercoiling in
compacting the genome. Our overall goal is to elucidate the underlying principles of bacterial
chromosome organization, which will impact our understanding of how genomic processes occur
in a realistic cellular environment.

Public health relevance
Project Narrative (3 sentences) This project investigates the molecular and cellular mechanisms contributing to the spatiotemporal regulation of two essential bacterial cellular processes, cell wall constriction and chromosome organization, using E. coli as a model organism. We will use in vivo and in vitro single-molecule imaging, computational modeling, and biochemical and mutational analyses to probe the molecular compositions, dynamics, functions, and regulations of key players of the two processes. Insights generated by this research will hold potential for significant advancements in microbial biology and therapeutics.